Development and Assessment of Live Microbiome-Based Products: Fecal Microbiota for Transplantation (FMT) and Live Biotherapeutic Products (LBPs) - COVID-19

This project will assess SARS-CoV-2 stool shedding and the risks of transmission.